Real-world utilization, effectiveness, and safety of GLP-1 receptor agonists for alcohol use disorder

PROJECT SUMMARY
Glucagon-like peptide-1 receptor agonists (GLP-1RAs), which are indicated for type 2 diabetes, obesity, and
cardiovascular disease, have been suggested as potentially effective treatments for alcohol use disorder (AUD).
However, evidence from observational studies and randomized controlled trials has been limited. One cohort
study found that GLP-1RAs may be associated with lower risk of subsequent hospitalization for AUD or purchase
of medications for AUD (MAUD) compared to other T2DM medications. However, since this study was conducted
in Denmark, the findings are not generalizable to patients with AUD in the United States. While trials of GLP-
1RAs for AUD are currently underway, these small trials will not provide direct comparative evidence across
MAUD, and are likely to underrepresent older, rural, and racially and ethnically minoritized populations. These
limitations have stimulated interest in using real-world data, causal inference methods, and novel machine
learning subgroup identification approaches to generate evidence to guide the selection of optimal AUD
treatment regimens in clinical practice. Therefore, we will use administrative claims data and linked electronic
health record and laboratory result data from OptumLabs® Data Warehouse (OLDW), which includes health
insurance claims for all Medicare fee-for-service enrollees and for commercial and Medicare Advantage
enrollees across the United States, to generate evidence relevant to the use of GLP-1RAs in real-world clinical
practice. We have identified 13,237 patients with AUD in OLDW who were prescribed GLP-1RAs from 2011-
2023. In Aim 1, we will follow the target trial emulation framework, which uses counterfactual theory to compare
the effects of sustained treatment strategies, to evaluate the comparative effectiveness and safety of GLP-1RAs
with both on-label (acamprosate, disulfiram, naltrexone) and off-label (gabapentin, topiramate, and varenicline)
MAUD. These analyses will address the lack of direct comparative evidence between GLP-1RAs and other
MAUD and will complement ongoing GLP-1RAs trials by providing evidence across more diverse and
generalizable populations and practice settings with longer observation periods. In Aim 2, we will examine trends
in GLP-1RA utilization among subgroups of patients with AUD, with a focus on potential differences in access to
and use of these medications by key demographic and clinical characteristics, including race and ethnicity,
rurality, gender, age, and co-morbidities. These analyses are essential to inform our understanding of potential
inequities in GLP-1RA use among patients with AUD. In Aim 3, we will use traditional and novel machine learning
subgroup methods to identify phenotypes of AUD patients more likely to experience beneficial or harmful
outcomes with GLP-1RAs or other MAUD in real-world clinical practice. Identifying phenotypes of AUD patients
will help guide clinical decisions, support higher quality AUD care, and inform the design of future clinical trials
of GLP-1RAs among patients with AUD.

Public health relevance
PROJECT NARRATIVE Glucagon-like peptide-1 receptor agonists (GLP-1RAs), which are indicated for type 2 diabetes, obesity, and cardiovascular disease, have been suggested as potentially effective treatments for alcohol use disorder. Given the lack of observational studies and randomized controlled trials supporting the use of GLP-1RAs among patients with alcohol use disorder in the United States, we will use a large observational database to evaluate the: 1) comparative effectiveness and safety of GLP-1RAs and other on- and off-label medications for alcohol use disorder, 2) trends in GLP-1RA utilization among subgroups of patients with alcohol use disorder, and 3) phenotypes of alcohol use disorder patients more likely to experience beneficial or harmful outcomes with GLP- 1RAs or other medications for alcohol use disorder in real-world clinical practice. These evaluations will help guide clinical decisions, support higher quality care, and inform the design of future clinical trials of GLP-1RAs among patients with alcohol use disorder.